Clinical Samples

The proposed analysis of immune responses generated after immunization in this project entitled,

Public health relevance
RELEVANCE (See instructions): The Clinical Sample Core will serve a vital function for properly maintaining and disseminating such an invaluable repository of samples resultant from this U19. The Clinical Sample Core will foster interactions between invesitgators, collaborators, and processing cores for this program project, which as a result, will lead to scientifically sound correlative studies and facilitate a truly synergistic program and not just a collection of projects.